Biobehavioral Cancer Prevention and Control Training Program (BCPT)

ABSTRACT
The Biobehavioral Cancer Prevention and Control Training Program (BCPT), a 20-year collaboration
between the University of Washington and the Fred Hutchinson Cancer Research Center, provides
interdisciplinary research training to pre-doctoral and post-doctoral trainees to prepare them to be the next
generation of leaders in cancer control research. The objectives of the program for the next 5 years are to: 1)
recruit excellent and diverse pre-doctoral and post-doctoral applicants from social and behavioral science-
based disciplines, as well as PhD or MD-trained basic or clinician scientists who wish to add a social and
behavioral sciences perspective to their cancer research; 2) provide trainees with an exceptional
interdisciplinary training experience that includes expert mentorship, research experience in active cancer
prevention and control projects, and leadership opportunities within those projects and within the trainee
community; and 3) skill development in grant writing, preparing scientific manuscripts and oral presentations
for conferences, and career planning. We propose to support two pre-doctoral and four post-doctoral trainees
each year; ideally each trainee would be supported for two years and we would support at least 18 trainees
over the 5-year period. We will also maintain our affiliate program to extend BCPT training and mentoring
opportunities to other trainees funded from different sources.
The unique collaboration between the University of Washington and the Fred Hutchinson Cancer
Research Center provides a rich array of qualified mentors, formal coursework, and cancer research projects
trainees engage with. We engaged faculty from multiple academic settings to train and support BCPT trainees;
these faculty will be a major presence in the next five years of training. Formal coursework at the University of
Washington is provided within the School of Public Health Departments of Health Systems and Population
Health, Epidemiology, and Biostatistics, the School's interdisciplinary programs in Public Health Genetics and
Public Health Nutrition, the School of Pharmacy, as well as within the School of Nursing for appropriate
candidates. Doctoral programs are offered in all these departments. Trainees will complete research
experience with their mentors at the Fred Hutchinson Cancer Center, the Seattle Cancer Care Alliance, and
the University of Washington. Over the life of BCPT, we have appointed 34 predoctoral fellows, 19 postdoctoral
fellows, and have provided support to 20 affiliated fellows (who were not funded through BCPT). The vast
majority of our trainees have completed BCPT and gone on to research careers in cancer control. The BCPT
provides trainees the knowledge, skills, and professional experiences they require to transition to successful
careers in cancer prevention and control.

Public health relevance
Narrative Cancer is the second leading cause of death in the United States. The Biobehavioral Cancer Prevention and Control Training Program (BCPT) prepares pre-doctoral and post-doctoral trainees for careers that will address the challenge of cancer prevention and control. The BCPT is a joint effort of departments in the Schools of Public Health, Medicine, Pharmacy, and Nursing at the University of Washington, the Fred Hutchinson Cancer Research Center, and affiliated institutions including the Seattle Cancer Care Alliance.